Molecular Mechanisms of Stellate Cell Activation in Liver Fibrosis

PROJECT SUMMARY
HCC is the 3rd most deadly malignancy in the world due to limited success in early and effective
therapeutic interventions. Behavior of HCC cells is predicated by tumor microenvironment (TME) which
comprises non-cellular and cellular components. One of tumor-associated cell types implicated in
promoting HCC is the hepatic stellate cell (HSC) which produces ECM components, matricellular
proteins and soluble factors to support HCC growth. Our research into the molecular mechanisms of
HSC activation, revealed a novel positive loop of canonical Wnt pathway mediated by stearoyl Co-A
desaturase (SCD). This loop involves sequential steps of β-catenin (CTNNB1) amplifying SREBP1c-
mediated transcription of Scd2; SCD2 raising cytosolic monounsaturated fatty acids which impair nuclear
transport of the mRNA binding protein HuR; and increased cytosolic HuR stabilizing Lrp5/6 mRNA and
upregulating their proteins, the functional Wnt co-receptors. Disruption of this loop by conditional Scd2
knockout in activated HSCs (aHSCs) in Scd2f/f;Col1a1Cre mice, attenuates cholestatic and hepatotoxic
liver fibrosis, and remarkably live tumor development. This tumor suppression is accompanied by global
repression of CTNNB1 and YAP1 in TME, suggesting SCD-dependent release of factor(s) by aHSCs to
achieve tumor promotion via global CTNNB and YAP1 upregulation. In search of such factors by
combinatorial transcriptomic and lipidomic analyses, we identified 12-HHTrE (12-
hydroxyheptadecatrienoic acid), the highest affinity lipid ligand for leukotriene B4 receptor 2 (LTB4R2)
as a putative driver for the novel 12-HHTrE-LTB4R2 tumor promotion pathway. 12-HHTrE is a major
eicosanoid metabolite released by murine primary aHSCs and human aHSC line LX2 cells. It is enriched
in wild type but not in Scd2ff/Col1a1Cre mouse liver TME. It induces via LTB4R2: 1) p-ERK1/2,
p(S9)GSK3β, and nuclear CTNNB1; 2) CTNNB1-induced YAP1 transcription via a TCF site in its first
intronic enhancer; and 3) nuclear YAP1 and YAP1-target genes in liver cancer cells. Single cell RNA
sequencing of mouse TME identifies a unique aHSC subpopulation which co-expresses both HSC
marker Lrat and fibroblast marker Fbln2, and selectively expresses Cyp1b1 but not other 12-HHTrE
biosynthetic genes. SCD or CTNNB1 knockdown (KD) reduces CYP1B1 expression and 12-HHTrE
release by aHSCs in culture. Finally, AAV8-mediated LTB4R2 KD in wild type mice, reproduces tumor
suppression observed in Scd2f/f;Col1a1Cre mice.
Based on these findings, we hypothesize that the most critical upstream event in the newly disclosed
LTB4R2 tumor promotion pathway, is increased12-HHTrE generation by CYP1B1 upregulated in tumor-
associated Lrat+Fbln2+ aHSCs and that this subpopulation is a plausible target for anti-HCC therapy.
To test this central hypothesis, we aim to determine: 1) if an emergence of Lrat+Fbln2+Cyp1b1+ aHSC
subpopulation is prevented by conditional Scd2 ablation in mice; 2) if SCD-CTNNB1 orchestrates in
aHSCs, CYP1B1 transcriptional activation and 12-HHTrE production via CTNNB1-AhR (aryl
hydrocarbon receptor) interaction and PGST2 (COX2) generation of PGH2 which serve as a lipid AhR
ligand to support CYP1B1 transcription and the substrate for CYP1B1 synthesis of 12-HHTrE; 3) if 12-
HHTrE generation is selectively inhibited in Lrat+Fbln2+ aHSC subpopulation to have therapeutic effects
on the development of hepatoma and progression to HCC in mice; and 4) if Lrat+Fbln2+ aHSC-targeted
CYP1B1 KD in HCC patient-derived xenograft (PDX) model achieves therapeutic efficacy.
A long-range goal of our research is to extend results from these specific aims to innovative designing
and development of novel aHSC-directed therapeutic modalities for HCC which inflicts many veterans.

Public health relevance
PROJECT NARRATIVE This VA Merit Review research will help understand how one liver cell type called hepatic stellate cell (HSC), promotes liver tumor development under alcohol drinking and Western diet consumption, the conditions which are prevalent among veteran patients. Our research has identified a lipid molecule produced by HSC as a novel driver for liver tumor development via a newly revealed tumor promotion pathway. Proposed research will pin-point a subset of HSC responsible for this pathway and test if its intervention reduces liver tumor development in a mouse model and in mice bearing human liver cancer. Findings from these studies will help develop a new therapeutic approach for liver cancer which continues to plague veteran patients.